Redox and other mechanistic insights into cancer and cardiovascular diseases

Our previous studies have suggested that oxidative stress may promote oxidative DNA damage/tumorigenesis and atherosclerosis. A major contributing factor to oxidative stress is ambient oxygen which is reduced by the mitochondria. Environmental and genetic methods will be used to modulate redox homeostasis and to determine their effect on energy metabolism, tumorigenesis, and cardiovascular function. In addition, we are examining the importance of maintaining mtDNA to prevent doxorubicin-induced cardiomyopathy and are investigating new strategies for diagnosis and prevention. We are also investigating the role of inflammation or immune-mediated mechanism in cardiovascular diseases using blood and tissue samples of mouse models and human subjects from translational studies.